Minimally Invasive Local Delivery of Cardiac Gene Therapy

PROJECT SUMMARY
Cardiovascular diseases (CVD) are the leading cause of death in the United States, and current therapies are
hindered by inefficient delivery methods, high systemic off-target exposure, and prohibitive costs, particularly for
gene therapies. Corami Biotech’s platform combines a minimally invasive epicardial delivery device (EpiCor™)
and a tunable hydrogel (GelCor™) which together localize therapeutic to the heart leading to significantly lower
effective dose of gene therapy compared to systemic delivery while minimizing off-target expression.

Public health relevance
PROJECT NARRATIVE Cardiovascular diseases (CVD) remain the leading cause of death in the United States, with over $280 billion spent annually on treatment, including $40 billion on drugs, yet current therapies remain inadequate. Cardiac gene therapy is a potential new treatment method for CVD, especially for those that may not find resolutions with other methods. Systemic delivery methods for cardiac gene therapy, such as intravenous or intracoronary administration, are hampered by low cardiac bioavailability, limiting efficacy at low doses and causing adverse effects at higher doses. Additionally, non-oncologic gene therapy costs exceed $630,000 per treatment as of 2024, posing significant barriers to patient accessibility. These challenges highlight the need for biomaterials- based innovations to facilitate safe, effective, and scalable delivery of gene therapies to the heart. Corami Biotech has developed a platform comprising EpiCor™, a minimally invasive epicardial delivery and placement device, and GelCor™, a tunable hydrogel designed for epicardial application. This platform localizes therapeutic delivery to the heart, reducing systemic exposure while potentially improving cardiac gene transduction rates. Preliminary rodent studies demonstrate that this platform achieves 10x dose reductions in vector dosing with significantly less off-target effects, while with SBIR Phase I funded research in large animal models validated a 250-fold dose reduction for an anti-arrhythmic drug. These findings suggest that Corami’s platform can overcome key barriers in the development of cardiac gene therapies. This Phase II STTR project will address critical challenges in cardiac gene therapy and in scaling biomaterials- based technologies towards clinical translation simultaneously. The project will validate the platform’s scalability and safety in a porcine model through advanced imaging, histology, and biomarkers. It will focus on minimizing dose, reducing immune activation, and preventing off-target expression. These efforts outlined in this project are directly aligned with the NOT-EB-24-001. By completing this work, Corami™ will establish a robust scalable platform ready for FDA engagement and posted for clinical translation and commercialization. This transformative approach addresses key barriers in cardiac gene therapy, offering a pathway to safer, more effective treatments for CVD.